The role of TIGIT in Treg-mediated suppression of C8+ T cells in Transplantation

Summary/Abstract
Transplantation is a curative strategy for end stage organ failure. In order to avoid immune-mediated rejection
of the grafted tissue, recipients receive life-long immunosuppression. Calcineurin and mTOR inhibitors for
immunosuppression are successful in preventing graft rejection but are associated with significant adverse off-
target toxicities. In order to better preserve the health of both the graft and the transplant recipient, alternative
immunosuppressive therapies have been sought. Belatacept, a CTLA-4Ig fusion protein, suppresses the
immune system by binding to CD80 and CD86 on antigen presenting cells (APCs) to block CD28
(costimulatory) and CTLA-4 (coinhibitory) signaling on T cells. By blocking interactions that are specific for
immune cells, the use of CTLA-4Ig mitigates off-target toxicities associated with calcineurin inhibitors and
increases the longevity of the graft and health of the patient. However, CTLA-4Ig is associated with increased
risk of acute rejection episodes compared to calcineurin inhibitors, which has prohibited its widespread clinical
adoption despite the improved long-term outcomes. Regulatory T cells are essential to maintaining immune
homeostasis and promoting tolerance in transplant, but the blockade of signaling through CD28 and CTLA-4 is
detrimental to their survival and function. Therefore, CTLA-4Ig therapy inhibits Tregs from controlling CD8+ T
cells as they execute acute rejection. Identifying costimulatory and coinhibitory pathways that can be targeted
to enhance the suppressive capacity of Tregs in the setting of CTLA-4Ig therapy is essential to improving
targeted immunosuppressive therapies. TIGIT is a T-cell inhibitory receptor with Ig and ITIM domains
expressed on Tregs that can be targeted with antibodies to fine-tune Treg function. Agonistic anti-TIGIT
antibodies have been shown to induce apoptosis of costimulation blockade-resistant memory T cells in a Treg-
dependent manner. The experiments outlined in this proposal study the mechanisms by which TIGIT signaling
on Tregs enhances Treg function in the face of CTLA-4Ig therapy to reduce CD8 + T cell responses to allograft
challenge. In Aim 1 we will determine if cell-autonomous TIGIT signaling increases the abundance of Tregs
within grafted tissue and increases the secretion of suppressive molecules to enhance Treg function. In Aim 2
we will determine the impact of Treg-specific TIGIT signaling on effector CD8+ T cell responses to allograft.
These studies will be performed using novel Treg-specific TIGIT knockout animals (Foxp3-Cre x TIGITfl/fl).
Together, these data will illuminate the therapeutic potential of TIGIT agonism in combination with
costimulation blockade therapeutics to mitigate acute allograft rejection.

Public health relevance
Project Narrative Transplantation is a curative strategy for end stage organ failure. Costimulation blockade with CTLA-4Ig is a promising therapy for post-transplant immunosuppression but comes at the cost of decreased Treg survival and function with increased acute rejection. We aim to study the therapeutic potential of targeting the inhibitory molecule TIGIT to synergize with costimulation blockade in inhibiting allograft rejection in a Treg-dependent mechanism.